Cancer Research Career Enhancement and Related Activities

PROJECT SUMMARY: CANCER RESEARCH CAREER ENHANCEMENT (CRCE)
The Fred Hutch/University of Washington Cancer Consortium aims to be at the forefront of training the next
generation of scientists and clinicians to best position them to lead efforts to eliminate cancer. Education and
training has always been a core value and central to our mission, and we propose here to continue to
emphasize and enhance our training mission and footprint. The specific aims for CRCE are (1) to provide
exceptional training and support for graduate students and postdoctoral and clinical fellows so that they will be
poised to tackle a range of careers in cancer research; (2) to encourage young students to engage in and
experience science and to provide exposure and opportunities for those from groups that are
underrepresented minorities (URMs) in science; (3) to maximize the success of junior faculty through
mentoring and support as they transition to independent scientists; and (4) to support the pipeline of
educational and training opportunities of the Consortium.
To support our training efforts, we host a large and comprehensive set of T32 grants (n=47), of which 32 have
Consortium faculty as mentors, 17 are led by Consortium PIs, and 7 are from NCI. The eight T32s with the
strongest cancer focus collectively support 39 trainees/year, and an additional 95 trainees are supported by
T32s that include cancer research as a component. Some of these grants have been in continuous existence
for more than 4 decades (e.g., Molecular & Cellular Biology, Medical Scientist Training Program, Medical
Genetics, Hematology). The caliber of our trainees and their success is illustrated by current active awards of 1
K99 grant, 6 K01 or K22 grants, 10 F32 grants, 2 Jane Coffin Childs Fellowships, 4 Damon Runyon Cancer
Research Awards, and 4 Susan G. Komen Fellowships. This Cancer Research Career Enhancement (CRCE)
component will serve as a centralized resource that integrates and supports these efforts, encourages the
continuum of training and mentoring, and supports continued innovation in our education pipeline.

Public health relevance
Not applicable to P30 CCSG as stated in the FOA PAR-17-095.